GLYCOGEN STORAGE DISEASE--BIOCHEMICAL DIAGNOSIS, CLINICAL PROGRESSION &THERAPY

The purpose of this study is to investigate 1) the effects of various dietary treatments or disease progression in the glycogen storage diseases (GSD), 2) the molecular basis of type III GSD, and 3) the mechanism and treatment of renal disease associated with type I GSD.